Clonotyping Airway T-cells to Uncover Microbiome-Specific Inflammotypes in HIV-associated COPD

Abstract
This is an application for the K43 Emerging Global Leader Award for Alex Kayongo, MD-PhD. Dr. Kayongo has
shown great promise as a young investigator in low- and middle-income countries (LMICs) investigating the
airway microbiome-host immune crosstalk in HIV-associated COPD. He proposes to gain advanced training in
implementing high-quality multi-omics COPD studies in LMIC settings, which require additional training and
mentorship. His career goal is to become an independent investigator and expert in the airway microbiome and
mucosal immunology of COPD in HIV. This award will provide Dr. Kayongo with the support and training to
accomplish this goal. He has assembled an experienced mentorship team, including Dr. William Checkley (USA-
based Primary Mentor, Professor of Medicine in the Pulmonary and Critical Care Division at the Johns Hopkins
School of Medicine and Dr. Moses Lutaakome Joloba (LMIC-based Primary Mentor, Professor of Molecular
Biology, Makerere University). The team will include key collaborators: Dr. Sofia Forslund (Charite University,
Professor of Applied Microbiology) and Dr. Miriam Moffatt (Imperial College London, Professor of Respiratory
Genetics). Through close mentorship and practical experience, Dr Kayongo proposes to accomplish advanced
training in multi-omics analysis.
COPD is increasing in prevalence among people living with HIV (PLWH) primarily due to the widespread use of
antiretroviral therapy (ART), which has increased longevity in this population. Sub-Saharan Africa, with the
highest density of PLWH, has experienced dramatic increases in COPD-related morbidity and mortality. Despite
viral suppression, it’s not fully known what drives chronic lung inflammation in this population. Lung dysbiosis,
reported to persist following ART initiation, could be a potential driver of chronic inflammation. Despite reported
links between COPD-specific bacterial taxa and immune dysregulation, there is limited understanding of the
breadth of such cellular immune responses. The fundamental question of how airway CD4+T cells integrate
diverse microbiome stimuli remains unanswered. This proposal aims to characterise in vitro CD4+T-cell
clonotypic library specific to airway microbiome signatures associated with COPD among HIV-infected
individuals in a rural Ugandan cohort. Using this library as a reference, we will characterise ex vivo the
microbiome-specific clonotypic landscape of broncho-alveolar lavage (BAL)-derived CD4+T cells obtained from
a cross-sectional cohort of individuals stratified by HIV and COPD in rural Uganda. From a pool of these BAL-
derived microbiome-specific clonotypes, we will uncover unique clonotypes driving inflammation, referred to as
“T-cell inflammotypes”. To validate these identified inflammotypes, we will determine clonotypic variations
in a sub-cohort of individuals transitioning from stable COPD disease to exacerbation. This effort will guide
therapeutics targeting microbiome-specific “inflammotypes” in COPD.

Public health relevance
COPD is an increasingly important comorbidity among people living with HIV (PLWH), including in the United States, where persistent airway inflammation remains poorly understood despite effective antiretroviral therapy. This project will define microbiome-driven, antigen-specific T cell responses (“inflammotypes”) that underlie chronic lung inflammation, using a unique Ugandan cohort that provides access to microbial exposures and disease phenotypes not readily captured in U.S. populations. The findings will generate mechanistic insights directly relevant to improving the prevention and treatment of COPD in PLWH and the general population in the United States.